Biomedical Core

The Biomedical core will perform all of the ultrasound evaluations and evaluate cardiac structure (e.g., LVM, relative wall thickness [RWT]), vascular function (e.g., arterial stiffness, FMD) and impedance cardiography of hemodynamic function at rest. In addition, evaluations of anthropometric and hemodynamic measures will be completed.